Project ASTHMA – Aligning with Schools To Help Manage Asthma and Improve Outcomes

PROJECT SUMMARY

Multicomponent interventions delivered in school-based health centers (SBHCs) have the potential to decrease asthma morbidity in children from poor neighborhoods. Asthma is the most common chronic disease in children. Children from poor neighborhoods account for a relatively greater percentage of asthma exacerbations, emergency department (ED) visits, and hospitalizations. These children often do not receive guideline-based asthma care, and adherence to daily preventive asthma medication is poor. Traditional health service delivery models where care is received in physicians’ offices have limited success in improving asthma outcomes in children from poor neighborhoods. As a result, these children often receive crisis-driven care rather than prevention-driven care. SBHCs can improve outcomes for children living in poor neighborhoods. SBHCs are staffed by advanced practice providers (APPs) who can assess and manage diseases. There are therefore minimal costs to integrating an asthma management program within this existing health care delivery model.
Project ASTHMA (Aligning with Schools To Help Manage Asthma) is a prospective, stepped wedge cluster randomized trial based on a successful pilot study, that aims to assess the effectiveness of SBHCs as a cost effective health care delivery model to reduce asthma symptoms, exacerbations, ED visits, and hospitalizations in children with uncontrolled asthma who live in poor neighborhoods. The intervention will take place in SBHCs located in 10 Buffalo Public Schools. The APPs at the SBHCs randomized to Project ASTHMA that year will be trained and supported to deliver guideline-based chronic asthma care. Students enrolled in Project ASTHMA will receive asthma assessments, spirometry, and preventive medication management from the APPs, directly observed therapy of their preventive asthma medication from school nurses to support adherence, and self- management support to improve adherence to home doses of asthma medication. Students enrolled at the SBHCs randomized to the enhanced usual care group who will receive spirometry by the research team and then be referred to their primary care provider for assessment and medication management. SBHCs are a financially and clinically sustainable health care delivery model, and have the potential to substantially decrease asthma morbidity. If disseminated, Project ASTHMA has the potential to improve the health of children in schools throughout the country. These improvements are likely to be cost-effective because over 2,500 SBHCs already exist in hundreds of cities and towns in the United States.

Public health relevance
PUBLIC HEALTH RELEVANCE Children with asthma from poor neighborhoods frequently do not receive guideline-based asthma care, and as a result, account for a relatively greater percentage of asthma exacerbations, emergency department visits, and hospitalizations. Project ASTHMA (Aligning with Schools To Help Manage Asthma) tests the effectiveness of school-based health centers as a delivery model to improve health outcomes by providing children with guideline-based asthma assessments and preventive medication management, directly observed therapy of their preventive medication to support adherence, and self-management support. If successful, this multicomponent intervention will represent a cost effective and sustainable model to reduce asthma morbidity in children, and has the potential to impact cities and towns throughout the United States where over 2,500 school-based health centers operate.